Targeting peptide Lv and its downstream signaling against ocular neovascularization

Project Summary
Anti-vascular endothelial growth factor (VEGF) therapies are widely used for treating ocular diseases with
neovascularization, but nearly 30% of afflicted patients are non-responders to anti-VEGF agents. In addition,
repetitive anti-VEGF treatments that are needed to block the recurring neovascularization often lead to unintended
side-effects including retinal detachment and even blindness. Thus, searching for VEGF-independent angiogenic
factors and unveiling their underlying mechanisms become an imperative clinical need to help combat the recurrence
of neovascularization and the resistance to anti-VEGFs in these diseases. Peptide Lv is a newly discovered
angiogenic peptide that is upregulated in the retinas of patients with early proliferative diabetic retinopathy (PDR)
and of mice subjected to oxygen-induced retinopathy (OIR), featuring ocular pathological neovascularization.
Although it has no sequence homology to members of the VEGF family and VEGF receptors (VEGFRs), peptide Lv
promotes angiogenesis in vitro and in vivo. An antibody against peptide Lv, anti-Lv, not only dampens VEGF-
elicited endothelial cell proliferation, it also effectively blocks pathological neovascularization in mice with OIR,
as well as laser-induced choroidal neovascularization. Furthermore, peptide Lv not only cooperatively promotes
VEGF-induced angiogenesis, but also elicits VEGF/VEGFR2/nitric oxide-independent vasodilation. Chronic
vasodilation of existing vessels causes increased vascular permeability, stimulates angiogenesis, and promotes
neovascularization. Vasodilators are associated with a ~70% increased incidence of early age-related macular
degeneration (AMD). Thus, peptide Lv might be involved in the pathogenesis of PDR and wet AMD via promoting
both VEGF/VEGFR2-dependent and -independent angiogenesis and vasodilation. However, the mechanistic role of
peptide Lv in mediating VEGF-independent angiogenesis and vasodilation is completely unknown. Peptide Lv is
able to augment the protein expression of intermediate conductance calcium-dependent potassium channels (IKCa)
in cultured endothelial cells. Activation of K+ channels in the endothelium, especially IKCa, is important in angiogenesis
that can be VEGF/VEGFR2-independent. Opening these K+ channels can also lead to VEGF-independent
vasodilation. Herein, the objective is to unveil novel cellular mechanisms of peptide Lv in VEGF/VEGFR2-
independent angiogenesis and vasodilation. The central hypothesis is that peptide Lv activates and augments IKCa
in retinal endothelial cells that consequently leads to VEGF/VEGFR2-independent angiogenesis and vasodilation,
the underlying mechanism of resistance to anti-VEGFs. Two Aims combining in vitro, ex vivo, and in vivo approaches
to decipher peptide Lv-IKCa axis in VEGF/VEGFR2-independent angiogenesis and vasodilation will be carried out by
using peptide Lv null (peptide Lv-/-), IKCa null (Kcnn4-/-), and vascular endothelial cell-specific knockout of VEGFR2
(VEGFR2iΔEC) mice. Completion of the proposed research will unveil new mechanisms of peptide Lv in VEGF/
VEGFR2-independent angiogenesis and vasodilation, which will have a direct impact on the future development of
blocking peptide Lv-downstream targets as a therapeutic tool against ocular pathological neovascularization.

Public health relevance
Project Narrative Anti-VEGF therapies are widely used to treat ocular diseases with neovascularization, but 30% of patients are non-responders to anti-VEGFs, so there is a critical need to search for other alternatives to help combat these problems. Peptide Lv is a newly discovered endogenous angiogenic peptide, and genetic deletion of peptide Lv effectively inhibits ocular pathological neovascularization in mice, indicating the involvement of peptide Lv in pathological angiogenesis. The objective of this application is to unveil new cellular mechanisms of peptide Lv in VEGF-independent ocular angiogenesis and vasodilation, and the long-term goal is to develop tools against peptide Lv and its downstream signaling to treat ocular vascular diseases, so the research proposed in this application is pertinent to part of the mission of the NIH, especially NEI, in garnering fundamental knowledge that will help promote the prevention and treatment of ocular neovascular diseases.